A scalable cloud-based framework for multi-modal mapping across single neuron omics, morphology and electrophysiology

Project Summary
Categorizing individual neurons into different groups, or cell types, is a classical approach to studying the nervous
system. With increasingly more tools being invented to observe the neurons, new criteria were created to
characterize different aspects, or modalities, of the cells. While these modality-specific categorizations have
enabled in-depth knowledge in neuroscience, the inconsistencies across different criteria leave data integration
across modalities technically difficult. In addition, disagreements of “similar cells” using different categorization
criteria have resulted in division of the neuroscience community into modality-centric subgroups. To solve this
problem, objective approaches to define cell similarities incorporating multiple modalities must be established
and developed in a way that is open, accessible, and engaging to the neuroscience community at large. We
propose to develop a broadly accessible cloud-based framework toward an integrative, multi-modal brain cell
atlas using novel, scalable analytics tools, leveraging federated BRAIN Initiative resources and community
engagement. The self-supervised learning methodology is purely data-driven, and allows highly accurate
identification of similar cells based on single or multiple modalities of measurements, without presumption about
modality-specific classes. It also enables cross-modality mapping, where unobserved measurements can be
inferred from single-modal data, achieving computational “scale-up” of the brain cell mapping efforts in low-
throughput modalities such as electrophysiology or morphology. With more multimodal data being collected and
added to the study, the algorithm accuracy of this inference will continue to grow in an automated way. The
open-source methodology will be productionized into cloud-native pipelines for individual modalities and for
cross-modality mapping, and installed in a cloud computing workbench as a part of the ecosystem, for scalable,
open data analyses. This cloud ecosystem will demonstrate access to BRAIN Initiative data repositories hosting
molecular (NeMO), neurophysiology (DANDI), and microscopy (BIL) data, such that datasets from different
sources can be brought into a common workspace for integrative analyses. Furthermore, the cloud ecosystem
will provide a user-friendly data portal for visualization and navigation of the multi-modal single cell data from the
repositories, as well as exploring the cell similarity query results. This ecosystem will support FAIR principles
and promote collaborative research and seek for extended integrations with data repositories. Through broad
engagement and outreach to neuroscience communities, this project will provide resources for building an
integrated brain cell atlas and facilitate the multimodal characterization of the brain.

Public health relevance
Project Narrative The project will establish an objective, data-driven single cell characterization methodology that is integrative of multiple data modalities, and also enables cross-modal feature inference. Incorporating the novel methodology, a cloud ecosystem will be developed that promotes open, scalable, and integrative data analysis across multiple neuroscience subdisciplines. The resulting multimodal brain cell atlas will transform our understanding of the nervous system across scales by establishing relationships between molecular and cellular phenotypes; and the cloud ecosystem will be a key resource for neuroscience data and knowledge integration.